Chemoprevention and therapeutic treatment of BRCA1 associated mammary tumors

Effects of PARP-1 inhibition on BRCA1 mutant cancer cells. BRCA1 and PARP1 are both involved in DNA-damage response and DNA-damage repair. Recent investigations have suggested that inhibition of PARP1 represents a promising chemopreventive/therapeutic approach for specifically treating BRCA1- and BRCA2-associated breast cancer. To study the genetic interactions between Brca1 and Parp1, we interbred mice carrying a heterozygous deletion of full-length Brca1 (Brca1(+/Delta11)) with Parp1-null mice. We show that Brca1(Delta11/Delta11);Parp1(-/-) embryos die before embryonic (E) day 6.5, whereas Brca1(Delta11/Delta11) embryos die after E12.5, indicating that absence of Parp1 dramatically accelerates lethality caused by Brca1 deficiency. Surprisingly, haploinsufficiency of Parp1 in Brca1(Delta11/Delta11) embryos induces a severe chromosome aberrations, centrosome amplification, and telomere dysfunction, leading to apoptosis and accelerated embryonic lethality. Notably, telomere shortening in Brca1(Delta11/Delta11);Parp1(+/-) MEFs was correlated with decreased expression of Ku70, which plays an important role in telomere maintenance. Thus, haploid loss of Parp1 is sufficient to induce lethality of Brca1-deficient cells, suggesting that partial inhibition of PARP1 may represent a practical chemopreventive/therapeutic approach for BRCA1-associated breast cancer. Next, we tested effect of PARP-1 inhibition on BRCA1 mutant cells by using a PARP-1 inhibitor, AG14361. We found that BRCA1-deficient ES cells are very sensitive to the treatment of AG14361. Cultured BRCA1 mutant cancer cells also show some sensitivities to AG14361. However, in allografts of mouse carrying BRCA1-/- mammary tumors, we only observe a partial inhibition of tumor growth in both the BRCA1-/- and BRCA1+/+ tumors. Our study indicated that additional mutations occurring during cancer progression may be a culprit, although the exact cause for the resistance of BRCA1-/- breastcancer cells to PARP-1 inhibitors remains elusive. These findings suggest that PARP inhibition may serve as an approach for the prevention of BRCA related breast cancer and may be useful in combination with other chemotherapeutic agents in the treatment of breast cancer. Currently we are screening other chemicals that can synergistically kill BRCA1 mutant cancer cells with AG14361.